EFFECT OF DIET ON URINARY HYDROXYPROLINE AND SERUM GLA PROTEIN

Early and late postmenopausal women are asked to collect urine on their ad lib diet and during one to four days of a gelatin-free diet in order to evaluate the optimal conditions for collection. Fasting spot urine samples and 24-hr. urine samples will be compared.